Ambient Temperature Molecular Detection of Sexually Transmitted Infections from Vaginal Swabs on a Power-free Device

ABSTRACT
Despite being easily treatable, STIs such as Chlamydia (infection with Chlamydia trachomatis) and Gonorrhea
(infection with Neisseria gonorrhoeae) represent the majority of reportable annual STI cases, indicating that
screening and detection efforts for these STIs are inadequate. Untreated infections with C. trachomatis or N.
gonorrhoeae can result in increased risk for HIV in both men and women, however, untreated infections in
women are more likely to result in long-term adverse health effects, such as pelvic inflammatory disease,
infertility, and pregnancy complications. As the majority of infections are asymptomatic in women, access to
accurate screening is critical in this population. Several barriers limit the screening habits of sexually-active
adults, including lack of privacy in clinical settings, fear of stigmatization by visiting a healthcare professional for
testing, and access to clinics, appointments, and results in a timely and equitable manner. Additionally, current
gold-standard STI tests are generally only available in-clinic, and require expensive heating or electrical
components, making regular screening expensive and inaccessible to the lay consumer. Alternative technologies
without these components do not provide PCR-level accuracy.
Sherlock’s goal is to develop a PCR-level STI diagnostic device to detect C. trachomatis and N. gonorrhoeae
from self-collected vaginal swabs, and which does not require any isothermal or cycled heating elements, battery
power, or force in the product design. Specifically, this project will utilize a proprietary amplification chemistry
based on high-sensitivity, high-specificity assays, in combination with a prototype microfluidic device design that
will control the timed assay amplification and produce an easy-to-read output. 300 vaginal swabs will be qPCR
screened for absence of target pathogens, then spiked with in-house cultured C. trachomatis and N.
gonorrhoeae. Aim 1 will identify the optimal filter and neutralizing chemical treatment to separate and neutralize
human genomic DNA which can obscure pathogen detection from samples, while Aim 2 will establish optimal
lyophilized reagent bead size and timing delay, and Aim 3 will assess the device sensitivity, specificity, and
failure rate using positive clinical samples. This project will aid in refining the prototype accuracy for validation
and extension to other STIs in Phase 2, and will demonstrate the potential of Sherlock’s proprietary amplification
chemistry and power-free microfluidics design for at-home PCR-level tests. By creating a heating and power-
free molecular test for C. trachomatis and N. gonorrhoeae that is accurate, transportable, easy-to-use and read,
and inexpensive, this device can be utilized by the lay consumer in point-of-need settings (at-home) rather than
only in point-of-care settings (in-clinic), thereby creating a more accessible and equitable STI screening product.

Public health relevance
NARRATIVE When left untreated, STIs such as Chlamydia (infection with C. trachomatis) and Gonorrhea (infection with N. gonorrhoeae) can result in long term adverse health effects that disproportionally affect women, including increasing risk of pelvic inflammatory disease, infertility, and pregnancy complications, however, barriers such as lack of privacy and accessibility to clinical settings, high screening technology price points, and stigma lead women to get screened for STIs less frequently than they would prefer. The proposed study aims to develop a low-cost, PCR-level-accuracy diagnostic device with an easy-to use and read interface for the detection of C. trachomatis and N. gonorrhoeae which can be utilized by the lay consumer at the point of need (at-home) rather than at the point-of-care (in-clinic), creating a more accessible and equitable technology to screen for STIs in women.